EFFECT OF OLTIPRAZ ON CYTOCHROME P450 ACTIVITY

That the cancer chemopreventive agent oltipraz modulates the catalytic activity of cytochrome P450, using selective in vivo probes, the effects of acute oral dosing w/lotipraz on individual cytochrome P450 (CYP) isoforms (CYP1A2, CYP2A6, CYP2C9, CYP2C19, CYP2D6, CYP2E1, and CYP3A) in healthy subjects.